Transbronchial diagnosis and characterization of pulmonary hypertension with Mechanomicroscopy

Project Summary
Pulmonary hypertension (PH) due to lung disease (Group 3) is one of the most prevalent and most lethal classifi-
cations of PH. Two critical issues impede the effective clinical care of this disease: 1) prolonged time to diagnosis,
due in part to the challenge of identifying the symptoms of the disease separate from those of the primary lung
disease; and 2) complications in treatment due to the presence of multiple etiologies and the corresponding
absence of a one-size-fits-all solution. Bronchoscopy is a commonly-employed procedure in the diagnosis, moni-
toring, and treatment of the lung diseases of this group, and with the right tools would offer the perfect opportunity
to simultaneously investigate the presence and development of PH as well. Our long-term goal is to provide a
clinically viable endoscopic imaging platform for the early detection and enhanced personalized treatment of PH
in patients undergoing bronchoscopy. This platform, Mechanomicroscopy, has the potential to assess pulmonary
arterial pressure and remodeling quickly and with minimal clinical friction during the bronchoscopic procedure,
resulting in 1) a significantly shortened path to diagnosis that doesn’t rely on the development of symptoms; and
2) direct structural assessments of pulmonary arteries that are suspected to be relevant to determining effective
treatment. The objective of this proposal is to develop and validate Mechanomicroscopy for the transbronchial
assessment of pulmonary artery pressure and arterial smooth muscle thickening, and to perform these assess-
ments across a diverse population of individuals with Group 3 PH. In Aim 1 we will implement technological
developments for our system that will allow us to identify pulmonary arteries in real-time, which will aid in the
clinical efficiency of our imaging. In Aim 2 we will evaluate our diagnostic imaging criteria in an animal model,
comparing and correlating our measurements of pulmonary artery pressure and pulmonary arterial smooth mus-
cle thickness with those of the gold standards of right heart catheterization and histology. We will conduct a
human study in Aim 3 in which we will image patients who have already undergone right heart catheterization
and who do not have severe PH, again comparing our pressure measurements with right heart catheterization
for human translation and analyzing arterial smooth muscle thicknesses across the diverse population to inform
future studies focused on personalizing care.

Public health relevance
Project Narrative Public Health Relevance Statement: The goal of this research proposal is to develop a novel optical imaging platform to quantitatively assess pul- monary artery smooth muscle remodeling and vasoconstriction transbronchially. We anticipate that our imaging technology will meaningfully impact the lives of individuals with pulmonary hypertension by enabling earlier di- agnosis and providing previously unknowable information relevant to personalizing care. This technology will be of the highest benefit to patients with existing lung disease who are already very susceptible to pulmonary hy- pertension and who may already undergo bronchoscopy in the course of diagnosing or monitoring their primary disease.